Developing Community-Responsive mHealth and AI/ML: Understanding Perspectives of Hispanic Community Members in Washington State

Mobile health applications (mHealth) and digital health sensors coupled with artificial intelligence and machine
learning (AI/ML) have the potential to become breakthrough technologies and support a holistic, preventive
model of healthcare. These technologies allow individuals to integrate their daily life activities with healthcare
delivery and are especially promising for patients living with 1 or more chronic conditions. mHealth
technologies are key to reaching populations who rely on mobile devices for internet access. They also have
the potential to reduce health inequities for those who face barriers to healthcare access because of cost,
geography, language, or systemic racism. However, if these technologies are developed without appropriately
incorporating the values of those intended to benefit from them, they risk exacerbating rather than alleviating
health disparities by amplifying existing structural assumptions in healthcare, resulting in technologies that are
unusable, unresponsive, or otherwise not appropriate for the sociocultural context in which people live.
Researchers developing mHealth and AI/ML technologies need a robust evidence base about community
values to inform technology development, including which health conditions are highest priority and tools to
support embedding community values throughout research.
This project will build on longstanding relationships that the University of Washington Institute of Translational
Health Sciences (ITHS) has developed with Hispanic communities across Washington State. We will examine
ethical questions about the potential benefits and burdens of mHealth and AI/ML from the perspective of
Hispanic-identifying community members and produce a prototype translational resource for mHealth and
AI/ML research and application development. This supplement brings together 2 key goals for ITHS:
(1) integrating community stakeholders at all stages of translational research, and (2) developing accessible
methods, tools, and education for informatics and machine learning. To advance these goals, we aim to:
(1) develop community-facing materials conveying key features of potential mHealth applications; (2) describe
perspectives of Hispanic-identifying community members in Washington State about the use of mHealth and
AI/ML; and (3) produce a prototype translational resource to guide mHealth and AI/ML researchers in
development of community-responsive technologies. This resource can be refined by future research teams,
both within the Clinical and Translational Science Award (CTSA) consortium and beyond, and can be used to
guide future work across patient populations and clinical scenarios.

Public health relevance
PROJECT NARRATIVE Mobile health (mHealth) applications such as wearable sensors and self-trackers coupled with artificial intelligence and machine learning (AI/ML) can empower people to track their health information over time and alert them to adverse health events. While mHealth has the potential to reduce barriers to healthcare access and improve health equity, to do so effectively it must be developed in alignment with patient and community values and experiences. In this project, we will use a community-centered approach to create a resource that teams can use to identify when and how to integrate community engagement into mHealth and AI/ML development to create ethical and equitable tools for patients.